CORE 4: TRAINING

CORE 4: TRAINING BIOCOMPUTATIONAL SCIENTISTS Simbios has a strong track record in training graduate students and post-doctoral fellows. We have access to training grant support and training programs across all the disciplines contributing to this Center. We have a five-year track record of training students and post-docs as part of Simbios (Table ES.1). We equip biomedical computation students and post-doctoral fellows with a broad set of tools, so that they are prepared to approach unanticipated research challenges that arise in the future. For students, we have engaged 25 of them (including 11 women. Table 4.1, Section 4) in the core Simbios mission, and supplemented their experience with new classes, workshops, and seminars. We are thus well positioned to continue as a leader in the education of biomedical computation scientists. For post-docs, we have created a community of junior scholars devoted to physics-based simulation called the Simbios Distinguished Post-doctoral Program which has supported 15 fellows, some of whom have already begun independent faculty positions in the field and continue to be Simbios collaborators